Developing a Robust and Efficient Strategy for Censored Covariates to Improve Clinical Trial Design for Neurodegenerative Diseases

Project Summary: Developing disease-modifying therapies for neurodegenerative diseases has been challenging, in part
because accurate statistical models to identify the optimal time for intervention do not exist. Models of how symptoms
worsen over time (i.e., the symptom trajectory) before and after a clinical diagnosis can help identify that optimal time.
These models can help pinpoint when a therapy could prevent a clinical diagnosis, or slow the disease after a clinical
diagnosis.
Yet modeling the symptom trajectory is not easy even for Huntington disease, a disease for which researchers
can track symptoms in patients guaranteed to develop it. Like other neurodegenerative diseases, Huntington disease
progresses slowly over decades, so studies that track symptoms often end before clinical diagnosis. This makes time to
clinical diagnosis right-censored (i.e., a patient's motor abnormalities will merit a clinical diagnosis sometime after the
last study visit, but exactly when is unknown), leaving researchers with the challenge of trying to model the symptom
trajectory before and after clinical diagnosis without full information about when clinical diagnosis occurs. The challenge
creates a unique statistical problem of modeling the symptom trajectory as a function of a right-censored covariate, time
to clinical diagnosis.
Tackling this problem by modeling the distribution for time to clinical diagnosis has long been thought to be
the best strategy. For years, we and others worked to develop reliable distribution models, but we found that if the
model is even slightly wrong, we get biased estimates of how the symptom trajectory changes as a function of time
to clinical diagnosis. This bias causes problems for clinical trials because they are incorrectly powered to determine
if a therapy modiﬁes the disease course with statistical signiﬁcance. We began seeking a strategy that estimates the
symptom trajectory as a function of time to clinical diagnosis without needing to accurately model the distribution for
time to clinical diagnosis. Our team developed such a strategy for a related problem: estimating a regression model
that has a covariate measured with error. Like a right-censored covariate, when a covariate is measured with error,
the covariate's true value and distribution are unknown. Rather than ﬁnding the correct distribution, our nontraditional
strategy accurately estimates the regression model even when the distribution for the covariate is mismodeled.
Our overarching objective is to develop a similarly robust strategy when we have a right-censored covariate, which
requires tackling challenges in three new areas: noninformative censoring (Aim 1), informative censoring (Aim 2), and
handling longitudinal measures of the symptom trajectory (Aim 3). Upon completion, our work will produce robust
estimates of the Huntington disease symptom trajectory as a function of time to clinical diagnosis. The work is timely,
given recent therapies that show potential for modifying the course of Huntington disease. Correctly powered clinical
trials will enable researchers to test these therapies and determine if they modify the disease course. Our strategy could
help design these clinical trials and push forward the science of Huntington disease and other neurodegenerative diseases.

Public health relevance
Project Narrative: Developing disease-modifying therapies for neurodegenerative diseases is notoriously diﬃcult and is exacerbated by the lack of accurate statistical models to identify the optimal time for intervention. Here, we will use ﬁve longitudinal datasets of Huntington disease, a genetic neurodegenerative disease, to propose new statistical strategies to accurately estimate the disease course. These strategies can be used to help researchers identify when an experimental therapy could best modify the disease course, and help design a well-powered clinical trial to test that therapy.